Cell-of-Origin Footprints of Passenger Mutations in Human Lung Cancer

Project summary / abstract
The normal cell of origin (COO) from which a cancer arises is fundamental to our basic notions of cancer
development. COOs are central to the standard of care for hematopoietic cancers, where they inform
prognosis and guide therapy. However, COOs are not incorporated into the clinical paradigms for treating lung
adenocarcinomas, an epithelial cancer that is among the leading causes of cancer death worldwide. The major
reason for this is that we still don’t know the COO for most lung adenocarcinomas or whether the COO varies
from patient to patient. One major scientific obstacle to addressing this question is the limited understanding of
lung cell types, and epithelial types in general. A second obstacle is lineage infidelity that occurs during lung
cancer progression, which can obscure the COO when one analyzes tumors morphologically or
transcriptionally. As a result, the field has been required to rely on genetically engineered mouse models,
which are still limited in their ability to fully recapitulate genotypes and clinical features of human lung
adenocarcinomas. Recent work by us and others in the field has shown that genome-wide patterns of
passenger mutations can provide a patient-specific COO signal. However, this hypothesis has not been tested
rigorously for lung cancer or for other malignancies. In this study, we investigate how passenger mutation
patterns inform COOs in lung cancer. In particular, we focus on noncoding surfactant protein gene (SPG)
insertions and deletions, which our recent study (Cell 2017) and preliminary data establishes as one of the
most common mutational events in lung adenocarcinoma (30-40% of patients). In this study, we hypothesize
that this mysterious but highly prevalent mutational pattern is a somatic genetic “tattoo” of alveolar type II (AT2)
cell origin in SPG mutant lung adenocarcinomas. We will investigate this through deep profiling of tumor
adjacent tissue using targeted and single cell sequencing. In addition, we will investigate whether SPG mutant
lung adenocarcinomas are associated with distinct evolutionary trajectories, with respect to their mutational,
transcriptional, and histological state. Finally, we will build on our preliminary studies that establish compelling
links between genome distributions of somatic single nucleotide variants (SNVs) in lung cancer and cell-type
specific gene expression profiles obtained from single-cell RNA sequencing of benign lung. These preliminary
data indicate that some lung adenocarcinomas may have proximal (club or basal cell) rather than distal (AT2
cell) origins. We will build on our initial findings, to generate and analyze higher depth atlases of healthy lung
and correlate the patterns of cell type specific transcriptional and open chromatin profiles with genomic
distributions of somatic SNVs. This work will provide some of the first direct evidence to map human lung
adenocarcinoma to specific COOs. Furthermore, our establishment of rigorous links between passenger
mutational patterns and COO in lung cancer may have broader applicability to the study of COOs in other
prevalent and deadly human epithelial cancers.

Public health relevance
Project narrative The normal cell of origin (COO) from which a tumor arises is central to the treatment of blood cancers but does not factor into the standard of care for lung adenocarcinoma, a leading cause of world cancer death. We will explore a novel approach to map COOs in lung cancer, where COOs are not precisely known, by using the patterns of passenger mutations in their genome. This work may provide a new way to identify COOs for individual tumor samples and build a much needed bridge between human lung cancer biology and mouse models of this disease.